CE19-001, Injury Health-related Equity across the Lifespan (iHeal)

ABSTRACT
The Harborview Injury Prevention and Research Center, representing a 5-state region of the Pacific Northwest,
aims to reduce the injury burden for children and adults. We are powered by a commitment to collaborative
community engagement as a key factor in improving “Injury-related Health Equity across the Lifespan” and
to reduce the overall burden of injury and violence. We describe a 5-year plan to grow injury control efforts to
advance the scientific base for the prevention and control of injuries, emphasize the development and adoption
of real world interventions, and undertake training for the next generation of injury scientists in complementary
fields. The proposed Core and research project efforts all focus on CDC/NCIPC injury research priorities. The
Administrative Core provides structural oversight and fiscal management for HIPRC’s research,
communications, training/education, and outreach efforts and makes innovative use of Advisory Board input.
Our Outreach Core includes Community Outreach Action and Policies and Programs Outreach Action arms,
tasked with building community collaborations in injury prevention and care research and with translating
results into public policy/best practice implementation. The proposed Training and Education and Research
Cores emphasize interdisciplinary and active community collaboration in the identification and setting of
training and research priorities and a commitment to health equity. The Research Core supports four research
projects and three exploratory projects. Two of the four projects address CDC NCIPC Director’s Priorities—the
opioid epidemic and suicide prevention—and two address other key CDC priorities—falls and traumatic brain
injury (translational project). Each research project addresses health equity priorities and leverages
interdisciplinary expertise to change the national paradigm for injury and violence prevention and control
research. This proposal combines a commitment to interdisciplinary and community-based collaborative injury
control efforts with a health equity lens.

Public health relevance
PROJECT NARRATIVE The Harborview Injury Prevention and Research Center, representing a 5-state region of the Pacific Northwest, aims to reduce the injury burden for children and adults. We describe a 5-year plan to grow injury control efforts to advance the scientific base for the prevention and control of injuries, emphasize the development and adoption of real world interventions, and undertake training for the next generation of injury scientists in complementary fields; all with a health equity lens.